Mitigation of Stress Responses By Protein Transfer Through Conjugation Machines

PROJECT SUMMARY
Conjugation systems are widely known for their roles in disseminating mobile genetic elements (MGEs) and
cargoes of antibiotic resistance, fitness, and virulence genes among many species of bacteria. The enormous
medical problem associated with MGE-transmitted antibiotic resistance is enhanced by the fact that
conjugation systems also code for surface adhesins or conjugative pili that promote intercellular contacts
favoring transmission and establishment of robust, antibiotic-resistant biofilm communities. Furthermore,
various environmental stresses, including antibiotics, have been shown to stimulate MGE transmission
whereas, conversely, MGE transfer induces the SOS response and activates movement of integrons, which
are reservoirs of antibiotic resistance genes. Adding to the myriad of ways conjugation can impact
development of antibiotic resistance and genome evolution, we have shown that a consequence of
conjugation-induced SOS is the elevated accumulation of mutations in recipient cells. To mitigate the
deleterious consequences of mating-induced mutation, here termed MIM, many conjugative elements carry
genes such as psiB and ssb whose products suppress the SOS response. In our studies of a model F plasmid,
pED208, we discovered that PsiB and SSB are delivered through the conjugation channel, also known as a
type IV secretion system (T4SS), to recipient cells. Furthermore, translocated PsiB and SSB suppress both the
SOS response and MIM in transconjugants. ssb and psiB genes are carried by the maintenance/leading
regions (MLRs) of F plasmids and many other conjugative plasmids, as are several other genes whose
products are predicted to promote establishment of the MGE following transfer to recipient cells By use of a
robust and quantitative Cre Recombinase Assay for Translocation (CRAfT), we have shown that pED208
conjugatively transfers at least 9 MLR-encoded proteins, as well as 7 chromosomally-encoded proteins with
predicted or known functions in DNA metabolism and stress mitigation. In Aim 1, we will define the functional
interplay of PsiB, SSB, and a third protein, PsiA, in modulating the SOS response and MIM in donor and
recipient cells during conjugation. We will also evaluate the broader biological roles of PsiB and SSB
translocation through studies of other model conjugation systems and intra- and interspecies matings, and by
assessing effects of exogenous stresses on MGE transfer and PsiB/SSB mitigation of stress responses and
mutation. In Aim 2, we will identify and characterize the biological functions of other translocated MLR proteins
encoded by the model F plasmid, pED208. We will define the repertoire of chromosomally-encoded
translocated proteins, and initiate studies exploring biological functions focusing initially on testing a hypothesis
that mating induces the oxidative stress response and translocated SodA mitigates this stress response.
Results of these studies will significantly expand our understanding of how conjugation systems contribute to
bacterial communication, stress modulation, antibiotic resistance, and genome evolution.

Public health relevance
Project Narrative Conjugative DNA transfer by bacterial donor cells induces the SOS response in recipient cells, resulting in the upregulation of factors serving to promote the integrity of DNA as well as error- prone factors that allow for improved cell survival at the cost of elevated mutagenesis. We have discovered that, during conjugative DNA transfer, donor cells additionally translocate proteins with demonstrated or predicted biological roles in mitigation of mating-induced stress and mutagenesis. Our proposed characterization of conjugation-driven intercellular protein translocation will enhance our understanding of the cellular consequences of horizontal gene transfer and contribute new insights into processes of public health relevance such as pathogenesis and acquisition of antibiotic resistance that are fueled by mutations.